Synthesis and Chemical Biology of Bioactive Natural Products

Project Summary/Abstract
This proposal describes our program focused on the development of novel chemical reactions for complex
molecule synthesis, innovative strategies for molecule synthesis, and the application of these reactions and
strategies to antimicrobial natural products
The objective of the proposed research is to develop a scalable and expedient approach to several bioactive
natural product families and leverage the synthetic work to develop new chemical probes and lead compounds
for therapeutic development. We have developed several programs in this regard over our previous 5 years of
NIH support and are excited to expand our efforts while advancing our existing projects to the next level. Of
particular interest to date are polycyclic guanidine, oxazolidinone, curvulamines and absyssomicins to explore
antimicrobial and/or anti-biofilm activity.
We expect that our synthetic work will provide new reactions to construct molecules of broad utility and lead
to approaches to natural products that enable their use as chemical probes. These synthetic studies are
complimented by in-house chemical biology studies to explore the activity and mechanism of both natural
products and analogs against clinically relevant diseases. Taken together, these efforts will provide a framework
for the development of new synthetic chemistry and potential lead compounds for the treatment of bacterial
infections as well as other diseases as new activity is uncovered.

Public health relevance
Relevance The development of new treatments for resistant bacterial infections and aggressive cancers is a pressing need for public health. Natural products or their analogs have served as a major source of new classes of drugs over the last century and this proposal targets the study of natural products that have potential to be employed as novel treatments for human disease.